DATA MANAGEMENT AND STATISTICS CORE

The purpose of the Data Management and Statistics Core is to provide the data management and statistical expertise that is vital to the orderly progress and success of the research projects and ancillary studies of the Emory University Alzheimer's Disease Center (ADC). In particular, the Data Management and Statistics Core will be responsible for the following activities related to the ADC: SPECIFIC AIM 1: To provide, manage and maintain a high-quality research database that supports the research projects, cores, and ancillary studies of the Emory ADC. SPECIFIC AIM 2: To provide statistical consulting and collaboration on the design, conduct, analysis and interpretation of Emory ADC research studies. SPECIFIC AIM 3: To cooperate with and share data with the National Alzheimer's Coordinating Center (NACC) and with other individual ADCs and AD researchers. SPECIFIC AIM 4: To preserve the confidentiality of all patient and control subject records.